Celebrating the Inspired and Inspiring Testis Biology- The XXVII North American Testis Workshop

Project Summary
This R13 application requests funds to support the XXVII North American Testis Workshop
with a thematic focus on “Celebrating the Inspiring and Inspired Testis Biology”, which will
be held on May 2-5, 2024, at the Embassy Suites Denver, in Denver, Colorado. The
meeting will be held immediately after the American Society of Andrology annual meeting,
which will take place on April 19 – 2 May at the same location. Since 1972, the North
American Testis Workshop has been the premier international forum for basic and clinician
scientists to present and discuss their recent findings on testis regulation and function. It
attracts 150-200 attendees from North America and around the world, approximately 30% of
whom are trainees. The requested R13 funds will help defray travel costs for 10 trainees or
young investigators selected for short talks from submitted abstracts and part of the housing
costs for the 19 invited speakers. The main goals for the Workshop are as follows: 1) to
provide a platform for dissemination and discussion of new discoveries on testis biology,
especially novel data obtained using the latest genomic, epigenomic, and single-cell
technologies. 2) To create opportunities for scientific exchange and collaborations among
peers to foster career growth and to ensure the continued advance of the field of testis
biology. 3) To offer a forum for trainees (fellows, post-docs, and graduate students) and
junior investigators (within three years of independence) to present their research, receive
feedback from senior investigators, and build professional relationships, all of which
are known critical for both intellectual and academic growth. 4) To encourage the
participation of women and underrepresented groups, including faculty and trainees of
racial and ethnic minorities and people with disabilities, in this workshop to foster their
intellectual and academic growth by providing them with opportunities to present their
work, receive feedback from peers, and build professional networks.

Public health relevance
Project Narrative This R13 application requests funds to support the XXVIIth North American Testis Workshop to be held on May 2-5, 2024, at the Embassy Suites in Denver, Colorado. The proposed meeting aims to bring together leading experts and trainees in the field of testis biology from North America and around the world to present and discuss their latest data and technologies that could lead to resolving important medical and public health issues.